Development of a Patient-Facing Portal for the Receipt, Interpretation and Tracking Utility of Pharmacogenetic (PGx) Data

ABSTRACT
Selection of medication for mental illness is generally through trial-and-error, with high rates of adverse reactions
and sub-optimal efficacy. Pharmacogenetic (PGx) data is thus of particular benefit to facilitate selection of safe
and effective medications and is cost effective, decreases resource utilization, and improves patient
engagement, with the potential to overcome medication non-adherence. Nevertheless, in the field of psychiatry,
patients' familiarity with PGx remains low, demonstrating the need for improved patient-facing PGx materials.
The objective of this project is to enhance sustained patient engagement with their genomic information by: a)
increasing patient understanding of PGx results by developing a consumer-focused patient report; and b)
facilitating patient-provider communication and shared decision making using PGx-guided medication selection
on an ongoing basis by increasing patient self-reporting of psychiatric symptoms using regularly administered
psychometric scales that are communicated to healthcare providers in real time. This ongoing self-reporting will
serve as the entry point to discussions regarding changes to medication regimens, which will be explained to
patients using the consumer-focused PGx report. Ongoing and consistent patient-provider communication is
known to reinforce patient engagement, further encouraging patient use of the tracking system. Provider use will
be encouraged through the billing codes available for remote patient monitoring. This project has three Specific
Aims. Aim 1 is to develop a PGx report that is more accessible to individuals without a biomedical background.
The Professional PGx assay report will be adapted using the AHRQ Health Literacy Universal Precautions
Toolkit, following which a user comprehension study will be conducted to assess understanding of the report by
lay individuals. Aim 2 is to integrate outcome tracking scales within the patient portal to support voluntary tracking
of patient outcomes longitudinally and ongoing shared decision making with healthcare providers. For this aim,
diagnosis-specific psychometric scales will be integrated into the patient platform, together with a patient
reminder system that will send text/email reminders to patients every 2 weeks with a link to the psychometric
scales, as well as a reminder system for a designated community member to further encourage patient
engagement. An alert system will also be developed to notify patients and designated community members if
scores change by >30% between evaluations, prompting the patient to speak to their healthcare provider. User
acceptance testing (UAT) will be performed to verify that the systems operate as intended. Aim 3 is to develop
an application programming interface (API) to report patients’ longitudinal psychometric scoring directly to the
healthcare provider portal to facilitate patient-provider communication and ongoing PGx-guided medication
choice. A provider alert system based on patients’ self-reported outcomes, including indications of suicidality,
will also be developed, followed by UAT. Successful project completion will, for the first time, combine longitudinal
patient outcome tracking and PGx guidance, for both patients and providers, in the mental health field.

Public health relevance
NARRATIVE In the field of mental health, pharmacogenetics is of particular benefit to facilitate the selection of safe and effective medications, and has the potential to improve patient engagement. Nevertheless, patients' familiarity with pharmacogenetics in psychiatry remains low, demonstrating the need for improved patient-facing materials. This project aims to enhance sustained patient engagement with their genomic information by developing a patient-facing interpretation of a professional pharmacogenetic report to increase patient understanding of pharmacogenetic results, and by facilitating patient-provider communication and shared decision making regarding pharmacogenetic-guided medication selection on an ongoing basis.